CONTROL OF FLUID EXCHANGE IN MAMMALIAN KIDNEY

Quantitative adjustments in the rat of renal sodium excretion constitute the major defense of man's extracellular fluid volume against the potentially disruptive effects of variations in the intake and extrarenal loss of sodium. Derangements of this renal homeostatic mechanism are a hallmark of diseases characterized by the formation of ascites and/or edema. Although effective therapeutic means are available for manipulating the rate of sodium excretion in the majority of edematous patients, considerable ignorance remains as to the mechanisms responsible for the retention of sodium. The aim of the studies under current investigation are: (1) To provide new information concerning the intrarenal regulation of sodium excretion in the rat using conventional clearance and microperfusion-micropuncture techniques and (2) To provide new information concerning the effects of experimentally induced alterations in renal hemodynamics on sodium and water handling by both the intact and isolated kidney of the rat. Such information will prove useful for an understanding of the normal mechanisms controlling sodium excretion, as well as for an understanding of the mechanisms of pathological sodium retention frequently encountered in clinical medicine.